CHEETAH Center for the Structural Biology of HIV Infection, Restriction, and Viral Dynamics

PROJECT SUMMARY
Studies in this Project are undertaken with the goal of advancing foundations required to tackle new frontiers in HIV-1
biology and medicine, including the development of cure strategies, broad antiviral therapeutics, and methods for delivery
of biologic therapeutics into target cells. To these ends, studies in Project 3, Multiscale Analysis and Modulation of Viral
Dynamics, will characterize HIV-1 proviral silencing and reactivation over a wide range of resolution scales, from living
animals to high-resolution structural studies, and will develop new methods aimed at protecting animals from enveloped
viral infections and designing new biologics delivery systems.
Studies in Aim 1 (In Situ Architecture of Virus Reactivation) will examine, across multiple size and resolution scales,
viruses and associated cells at sites of HIV/SIV rebound in animal models. Specifically, we will: 1) locate and image
reactivating virus and associated cells, and 2) define the transcription profiles of infected and neighboring cells at rebound
sites.
Studies in Aim 2 (Proviral Silencing and Reactivation) seek a molecular and structural understanding of how HIV-1
silencing is established and maintained. To this end, we will determine structures, interactions, and mechanisms important
for latency, with a focus on the H3K9-specific methylase SETDB1, and on HUSH, which localizes on H3K9me3 and
collaborates with SETDB1 to promote the spread of H3K9me3 and heterochromatin.
Studies in Aim 3 (RetroCHMP3 Blocks to Viral Dissemination) will build on our recent discovery of retroCHMP3 proteins,
which are naturally-occurring factors that potently inhibit release of enveloped viruses that use the ESCRT pathway for
budding, including HIV-1. Our goals are to optimize retroCHMP3 potency in mouse cells lines by increasing protein
stability, expression, and restriction activity, and then create transgenic mice that express the optimal constructs and test for
broad resistance to enveloped viruses.
Studies in Aim 4 (Virus-Inspired Designed Delivery Systems) will generate new virus-inspired technology platforms for
intercellular delivery that are simple, robust, and controllable by taking advantage of: 1) recent developments in
computational protein design, 2) our previous successes in harnessing the principles of HIV-1 assembly to develop
nanoparticles that can direct their own self-assembly and bud from cells, and 3) our new advances for incorporating
transmembrane proteins into those particles.

Public health relevance
PROJECT NARRATIVE Research in this Project is designed to create the foundations necessary for developing treatments that could cure HIV patients, broadly protect animals against infection by enveloped viruses, and deliver biological therapeutics more effectively.